3D Printing Hydrogel Vasculature and Bioactive Cues within Brain Organoids

PROJECT SUMMARY
Brain organoids hold great potential for understanding neurodevelopmental and neurodegenerative diseases.
However, their utility is constrained by several factors including necrotic core formation, immaturity, and high
variability. This project aims to develop a robust and reproducible in vitro method for growing brain organoids
with improved structural complexity, cellular diversity, and long-term viability. Additionally, it seeks to gain
biological insights into how substrate stiffness, perfusion, and neural peptides affect brain organoid growth,
maturation, and function. The project will utilize 3D printing to create vascular-like networks using synthetic
multidomain peptide (MDP) hydrogels within the interior of brain organoids, while also providing brain-specific
mechanical and peptide signaling cues.
The first aim of the project is to investigate how the stiffness of MDP hydrogels impacts the growth and function
of organoids grown around the hydrogel. The second aim involves using a 3D printed hydrogel vasculature within
the organoids to determine whether perfusion through this vascular network prevents necrotic core formation.
The third aim focuses on incorporating neural peptide cues into the MDP hydrogels and exploring their effects
on improving cellular diversity and maturation within the brain organoids.
The findings from this project will guide the development of a novel method for growing brain organoids in a
reproducible and physiologically relevant manner, enhancing their utility for the study of neurodevelopmental
and neurodegenerative diseases. The long-term objective is to establish robust methods for growing brain
organoids that more closely mimic the human brain, offering a valuable platform for therapeutic development
and disease modeling.
Research will be conducted at the Salk Institute for Biological Studies and under the mentorship from Dr. Fred
Gage. This project will utilize a range of quantitative neuroscience technologies and offer valuable training
opportunities.

Public health relevance
PROJECT NARRATIVE This research project aims to address key limitations of brain organoids by developing a bioengineered solution to improve their growth, maturation, and reproducibility. By optimizing a 3D printed synthetic hydrogel scaffold with hollow vascular networks and bioactive mechanical and peptide signaling cues, this project seeks to create brain organoids that more accurately reflect human brain complexity, allowing for the study of neurodevelopmental and neurodegenerative diseases. The long-term impact of this research could lead to better in vitro models for drug screening and therapeutic development, ultimately improving treatments for brain-related disorders.